Biological Imaging Module

The Biological Imaging Module of the Center Core Grant for Vision Research provides state of
the art imaging facilities to support and advance innovative research by investigators at the
University of Houston. The Module provides a wide range of up-to-date imaging equipment for
use by Core investigators and their collaborators, and newly hired investigators, who have
interests in structural, cellular, and molecular aspects of vision research. Specifically, the Module
provides facilities for tissue preparation, standard light microscopy, confocal microscopy,
deconvolution fluorescence microscopy, two-photon microscopy, light sheet microscopy, live cell
imaging, transmission electron microscopy (TEM), scanning electron microscopy SEM and serial
block-face (SBF-SEM) imaging, computer-assisted image segmentation and 3D reconstruction,
and Retinal and Corneal Tomography and Spectral Domain – Optical Coherence Tomography
(SD-OCT) for in vivo imaging of small animals. The Module is staffed by two a highly skilled
personnel: an expert microscopist/histology technologist and an accomplished biophysical
microscopist with expertise in many aspects of advanced light microscopy. These individuals
coordinate use, assist with histology/microscopy and provide a full range of training that spans
basic to advanced techniques. The Biological Imaging Module is supervised by Nimesh B. Patel,
OD, PhD who has two active R01 grants funded by NEI, substantial expertise in light and electron
microscopy, and in vivo OCT imaging and computer-assisted image analyses.